Assembly and function of cytoskeletal systems in eukaryotic and prokaryoticcells

Project Summary/Abstract
My laboratory pursues answers to fundamental questions in cell biology. Broadly, we study how self-assembly
of complex macromolecular structures —especially cytoskeletal polymers and networks— creates spatial order
in living cells. To understand how molecular properties govern the architecture and function of living cells, we
perform quantitative studies at multiple size scales: (i) single-molecule and bulk biochemical studies of
cytoskeletal components; (ii) biophysical and microscopical studies of complex cellular structures reconstituted
in vitro; and (iii) cell biological and high-resolution microscopy studies of cytoskeletal systems in living cells.
Our work currently addresses the following topics: (1) function and regulation of actin network motors that
make use of the Arp2/3 complex; (2) pseudopod assembly and amoeboid locomotion; (3) autophagy and
endomembrane movement; (4) nuclear actin assembly and DNA repair; and (5) assembly and function of
cytoskeletal elements in eubacteria and archaea. As part of an international consortium we have also recently
begun work to understand how SARS-CoV2 induces formation of long, branched filopodia in infected host cells
and what function these filopodia play in viral egress and spread.

Public health relevance
Project Narrative The goal of this proposal is to understand how the self-assembly of molecular bio-polymers gives living cells their shape; helps them to organize their contents; and enables them to move. This is important because it will help us to understand the mechanisms underlying many pathological conditions, including: developmental defects, cancer metastasis, immune cell malfunction, and viral infection.